The Duke Senescent Cell Evaluations in Normal Tissues (SCENT) Mapping Center

ABSTRACT –SCENT– Overall
Cellular senescence is a stress-response, as well as a critical component of cell fate during development, repair,
resilience and normal aging. Deepening and broadening our investigations into cellular senescence in normal
condition will advance our knowledge of healthy aging as well as age-related disabilities, thereby leading to
integrated and inclusive approaches to Gero-Protection and Gero-Therapeutics. A comprehensive, high-
resolution, Atlas of cellular senescence in various human tissues based on multimodal and multidimensional
analyses is required to address this need. The Duke Senescent Cell Evaluations in Normal Tissues (SCENT)
U54 Tissue Mapping Center (TMC) will leverage the broad and world-leading expertise of Duke University School
of Medicine faculty to contribute to the overall goal of mapping senescent cells at single cell resolution in normal
human tissues of across age-span and demographics. We will take advantage of Duke's broad expertise in many
areas, including pulmonary critical care, lung and heart transplant surgery, translational research, and
bioinformatics, to collect high-quality normal tissue specimens for biobanking, multimodal, high-resolution
analysis, and data integration to fully characterize cellular senescence in human organs and tissues.
The Duke SCENT TMC will be organized around 4 Cores as required by SenNet:
The Administrative Core (AC) of this TCM will provide guidance and leadership to the other cores and
communicate with NIH Staff and the SenNet Consortium during the set-up phase to agree on common protocols.
The Biospecimen Core will establish best practices for prospective acquisition, preservation and processing of
diverse, high-quality normal healthy human tissues and associated biofluids.
The Biological Analysis Core will deliver state-of-the-art profiling, led by a team of highly accomplished
research scientists who have successfully utilized these specific platforms in conjunction with previous and/or
current senescent analyses.
The Data Analysis Core (DAC) will manage, process and analyze the data generated to profile senescent cell
signatures and construct senescent cell tissue maps, as well as collaborate with the Administrative Core to
coordinate sharing of data, methods and pipelines with other SenNet institutions.

Public health relevance
Narrative – Overall: Senescent Cell Evaluation in Normal Tissues Senescence is a critical part of aging but remains poorly understood. Our proposal will apply new single cell technologies in different organs across the age spectrum to identify and understand how human senescence happens, with a goal of designing unbiased, data-based, targeted therapies for a range of aging-related diseases.